Improving Pulmonary Fibrosis Classification with Genomics Informed Phenotypic Clusters

PROJECT SUMMARY/ABSTRACT
Pulmonary fibrosis (PF) is a destructive interstitial lung disease (ILD) characterized by profound scarring. In
severe PF, death generally ensues within 3-5 years. While current classification criteria guide diagnosis,
prognosis and treatment of PF, substantial heterogeneity in PF phenotypes limit the utility of these criteria.
Many patients classified as idiopathic PF may belong to alternative PF subclasses, and a significant minority of
patients are unclassifiable. Recent genomic advances have identified factors that influence heterogeneity in PF
however, exclusion of major racial groups from these genetic studies limits the generalizability of their findings.
In this proposal, I aim to improve disease classification and outcome prediction in patients with PF. I will do this using
cutting-edge statistical tools and DNA samples collected from patients across diverse races. My central hypothesis is
that inclusion of genomic biomarkers from diverse races into a cluster-based model will lead to better PF
classification. I will first perform targeted genotyping for PF-associated gene variants and measure telomere lengths
to determine their variation across US racial groups with PF. I will then derive and validate a PF cluster model using
clinical data from racially diverse PF populations and determine the additional value of genomic data on outcome
prediction. Finally, using this model, I will determine heterogeneity of treatment effect on outcomes across patients
prospectively enrolled in national PF registries. Successful completion of this proposal will result in a validated
Clusters Across Subgroups of Pulmonary Fibrosis (CLASS-PF) model applicable in patients from diverse races to
improve PF classification and outcome prediction. My preliminary studies in clinical prediction modeling, and completion
of a Master’s Degree in Public Health Sciences have provided a solid foundation for success in this investigation.
My long-term career goal is to utilize genetic data from diverse races to improve clinical decision-making and
outcomes for patients with PF. To achieve this, I have formulated a career development plan that will provide
exceptional mentorship, and training in genomic analyses, statistical genetics, big-data analysis and clinical
trials. Leading experts in ILD, genetics, and risk-stratification modeling will mentor me. I have also assembled a
multidisciplinary advisory committee with expertise in telomere disorders, clinical trials, and biorepository
processing. The outlined work will be performed at the University of Chicago, an institution with established
track record of excellence in patient-oriented research, and abundant resources for collaboration. This K23
award is fundamental to achieve successfully the goals outlined in this proposal, as it will provide dedicated
time to attain these realistic milestones and acquire the skills to independently develop genomic prediction
tools that integrate clinical phenotype data for subsequent validation in clinical trials. This work will provide an
invaluable pharmacogenomic resource for studying PF across diverse races, and improve PF classification
and prediction thus channeling discovery into translation and ultimately to clinical implementation.

Public health relevance
PROJECT NARRATIVE Pulmonary fibrosis (PF) is a destructive interstitial lung disease with no known cure and leads to death within 3-5 years in severe cases. Substantial heterogeneity in PF phenotypes limits the utility of current classification criteria in prognostication and treatment. This proposal is critical to improving PF classification and prognostic accuracy, by incorporating critical genomic factors from diverse races into a new classification scheme using cutting-edge statistical tools, thereby guiding personalized therapy in PF.